AAFCO Feed Administrators Seminar

2022 AAFCO Feed Administrators Seminar
Project Summary/Abstract
PAR 19-306
The Association of American Feed Control Officials (AAFCO) is a voluntary membership
association of local, state and federal agencies charged by law to regulate the sale and distribution of
animal feeds and animal drug remedies.
AAFCO’s 2022 Feed Administrators Seminar provides an annual leadership conference for
animal feed regulatory agency administrators that includes leadership development sessions to assist
the agency administrators in enhancing skills so their on-the-job performance increases.
The AAFCO Feed Administrators Seminar offers a collaborative forum for the discussion of
animal feed agency management and regulatory topics. Registration for our Administrators Seminar is
open to state and federal government regulators, laboratory management, and the AAFCO Board of
Directors. A registration fee is charged on an individual bases to cover the expenses of providing the
meeting and associated food and beverage, audio/visual support, and meeting space.
All agency administrators employed by state and federal government agencies engaged in the
regulation of animal feed are invited to attend the meeting.
Attendance is typically 60 people from state and federal government regulatory agencies
including FDA CVM and ORA. Over the course of 2-1/2 days, the Administrators Seminar program offers:
• Panel discussions featuring the experiences of the Administrators
• Leadership training sessions
• New trends in leadership for administrators
• Networking opportunities throughout the day
• Access to the session materials after the conference
AAFCO intends to utilize grant funding to ensure the 2022 Feed Administrators Seminar provides
attendees with a robust experience through exposure to diverse perspectives on regulatory and
scientific topics that may be the continuation of ongoing work of members or trending scientific or
regulatory information of interest to the audience.

Public health relevance
2022 AAFCO Feed Administrators Seminar Project Narrative PAR 19-306 Funding from this grant will allow the Association of American Feed Control Officials (AAFCO) to host the 2022 AAFCO Feed Administrators Seminar. This leadership development conference will provide informative animal feed regulatory agency leadership with access to presentations and a collaborative forum for the discussion of animal food regulatory agency leadership issues.